Metabolic Function of Gpr17 in Gastrointestinal Tract

PROJECT SUMMARY/ABSTRACT
Metabolic diseases, such as diabetes and obesity, affect millions of individuals in the United States leading to
significant morbidity and mortality. While intensive lifestyle intervention and bariatric surgery are common
treatment approaches, lifestyle intervention is not typically durable in the long term, and surgical procedures
carry the risk of complications. Hence, there is a critical need to identify novel druggable targets to effectively
treat diabetes and obesity. G protein–coupled receptors (GPCRs) regulate important physiological functions
through a diverse array of ligands and are the most successful class of druggable targets. Therefore, elucidating
the physiological function of GPCRs in key metabolic organs holds promise to the development of novel
therapeutics for metabolic diseases. In recent years, gastrointestinal (GI) tract has become an emerging
therapeutic target for metabolic disease therapy. Incretins, including glucagon-like peptide 1 (GLP-1) and
glucose-dependent insulinotropic polypeptide (GIP), are gut hormones secreted by the enteroendocrine cells
in the gut to regulate glucose metabolism and energy balance via endocrine and neural mechanisms. The
release of incretin hormones is tightly regulated by G protein-coupled receptors (GPCRs) and their cognate
ligands. However, pathways regulating endogenous gut hormone secretion are not completely understood. We
recently discovered that GPR17 is expressed in the GLP-1 (but not GIP)-producing cells in human gut. The
overall goal of this proposal is to elucidate the metabolic function of Gpr17 in the GI tract. Our preliminary data
showed that loss of Gpr17 in gut epithelium leads to improved glucose tolerance with increased glucose-
stimulated insulin and GLP-1 (but not GIP) secretion. Gpr17 gut knockout mice also exhibit increased satiety
during fasting-refeeding challenge. Based on our preliminary data, we hypothesize that inhibiting Gpr17 function
in the gut improves glucose homeostasis and increases satiety via modulating enteroendocrine cellular function
and gut hormone release. To test our hypothesis, we propose the following studies. In Aim 1, we will determine
the role of intestinal epithelial Gpr17 in glucose homeostasis by measuring nutrient-stimulated GLP-1 and other
gut hormone secretion and systemic insulin sensitivity. In Aim 2, we will determine the role of intestinal Gpr17 in
satiety regulation by examining the effects on gut physiology and vagal sensory system. In Aim 3, we will
functionally characterize Gpr17 signaling and identify molecular mechanisms to potentiate GLP-1 secretion in
enteroendocrine cells. Our preliminary data and the demonstrated availability of in vitro and in vivo models
support the feasibility of our proposed study. Upon successful completion of this proposal, we expect to
determine the metabolic effect of Gpr17 signaling in the gut on systemic glucose metabolism and satiety
regulation. These studies will lay the foundation for identifying novel molecules that target Gpr17 in the brain-gut
axis for the development of potential therapeutic approaches.

Public health relevance
PROJECT NARRATIVE Metabolic diseases, such as diabetes and obesity, are costly chronic diseases and affect millions of individuals in the USA leading to significant morbidity and mortality. By using experimental mouse models and in vitro cellular assays, we will determine the mechanisms by which a G-protein coupled receptor in gastrointestinal tissue regulates energy and glucose homeostasis. This study will shed a light into the molecular pathways that mediate nutrient sensing and hormone secretion in the gut, which may provide therapeutic potentials to treat diabetes and obesity.